GENETICS OF FAT MEALS IN FAMILIES WITH PREMATURE CORONARY HEART DISEASE

The goal is to investigate whether the postprandial hypertriglyceridemia and or hypercholesterolemia is associated with premature coronary artery disease and type B LDL subclass pattern are an inherited defect.